Method validation for the detection of aflatoxins in fish feed using the ROSA-M Charm reader

PROJECT SUMMARY/ABSTRACT The PADLS New Bolton Center Toxicology Laboratory proposes to expand the capacity for detection of mycotoxins in animal feeds through the analysis of aflatoxins in fish feed using the hand-held Charm ROSA-M reader. We have previously validated this qualitative rapid lateral-flow method for the detection of aflatoxins in dog food as outlined in the Guidelines for the Validation of Chemical Methods for the FDA FVM Program, 2nd Edition. After completing the validation for aflatoxins in our laboratory, samples will be sent out for validation to 3 other collaborating Vet-LIRN laboratories. Each collaborating Vet-LIRN laboratory will report their analytical results accompanied by any method modifications or analytical problems. The results will be statistically evaluated and results from each laboratory will be evaluated for major discrepancies, displaced means, and any outlying values. Upon review of the data reported by the collaborating Vet-LIRN laboratories, a standardized method standard operating procedure (SOP) for the analysis of aflatoxins in fish feed using the Charm ROSA-M reader will be prepared and submitted to the Vet-LIRN Program Office for review and eventual method transfer to other Vet-LIRN laboratories.

Public health relevance
PROJECT NARRATIVE The PADLS New Bolton Center Toxicology Laboratory plans to further develop and validate analytical methods that will expand the ability to detect mycotoxins known to be harmful to humans and animals in animal feeds. This proposed work will better enable early detection of emerging events of public health importance involving animal food safety and security by building diagnostic laboratory capacity that will facilitate rapid national responses that can minimize harm and best protect both human and animal health.